The impact of the dermal ECM microenvironment on cutaneous aging and cancer

ABSTRACT
The major goal of this grant application is to determine the molecular mechanisms by which age-related
elevation of matrix metalloproteinase-1 (MMP1) in dermal fibroblasts creates a microenvironment that promotes
the aging process and age-related skin pathologies, including cancer.
Aging affects all individuals and is the single greatest risk factor for most common diseases, including cancer.
The characteristic features of aged human skin include dermal thinning, wrinkles, sagging and loss of elasticity,
resulting from disruption and degradation of collagen, the major structural protein in skin. Deterioration of
dermal collagen ﬁbrils is also directly connected to age‐related skin morbidities, such as tearing, bruising, poor
wound healing, and critically contributes to weakened immunity, and cancer. We found that matrix
metalloproteinase-1 (MMP1), which initiates cleavage of collagen fibrils, is significantly increased in aged
human skin dermal fibroblasts. This increase is associated with fragmentation and disorganization of collagen
fibrils and creates age-related aberrant extracellular matrix (ECM) microenvironment in the dermis (dermal
aging).
Based on above human skin in vivo data, we have recently generated a mouse model of skin dermal aging by
fibroblast-specific expression of human MMP1, the source of the elevated MMP-1 in aged human skin, driven
by a stromal cell-specific pdgfra-Cre transgene (pdgfra-Cre;MMP1). pdgfra-Cre;MMP1 mice exhibit
significantly accelerated dermal aging, which closely mimics those observed in aged human skin. Importantly,
pdgfra-Cre;MMP1 mice have substantially increased susceptibility to skin cancer/papilloma development,
suggesting dermal aging microenvironment promotes age-related keratinocyte skin cancer.
Based on these findings, we hypothesize that age-related elevation of MMP1 in dermal fibroblasts leads to
progressive alterations of the dermal ECM, which creates a microenvironment that promotes the dermal aging
process and age-related skin pathologies, including cancer. This data-driven hypothesis is based on a novel
concept that skin dermal aging is governed by the adaptation of fibroblasts to the surrounding extracellular
matrix (ECM) microenvironment (outside-in adaptation), rather than cell‐autonomous factors. We propose
following Specific Aims to test above hypothesis. Aim 1: Determine the Molecular Signatures/Pathways
During Dermal Aging Process. Aim 2: Investigate Mechanisms by which Dermal Aging is Driven by Fibroblast
Adaptation to the Surrounding ECM Microenvironment in a Non-Cell-Intrinsic Manner. Aim 3: Define the
Impact of Ageing of the Dermal Microenvironment on Keratinocyte Cancer Initiation. This proposal is
innovative and may have profound impact on the field of aging and age-related diseases by identifying age-
related ECM microenvironment as a key target for therapeutic intervention.

Public health relevance
Project Narrative The major goal of this grant application is to determine the molecular mechanisms in which MMP1 regulate age- related skin dermal extracellular matrix (dermal aging), and the impact of these processes on the pathogenesis of many age-related skin diseases. In this application, we propose a novel concept that dermal aging process is driven by fibroblasts adaptation to deleterious surrounding ECM microenvironment. Thus, we view skin dermal aging as “outside-in adaptation”; age-related deterioration of the dermal ECM (composition, structural integrity, organization, and mechanical properties) drives cellular aging by altering ﬁbroblast spreading/mechanical force and impairing MMP1 activity.